Retinoic Acid Signaling and Cardiac Cell Differentiation

[unreadable] DESCRIPTION (provided by applicant): Congenital heart defects are some of the most common birth defects. To understand the nature of these defects it is important to study signaling pathways, like Retinoic Acid (RA) signaling, which is required for normal heart development. RA signaling is important for cell differentiation in adult and embryonic tissues. Loss of RA signaling in adult tissues can lead to cancer and in embryos leads to developmental defects. Too much RA signaling can also be teratogenic. Thus, modulation of RA signaling levels is important for proper cell differentiation. The Yelon, using zebrafish, recently discovered a new role for RA signaling in proper cardiomyocyte progenitor selection. Without RA signaling, too many cardiomyocyte progenitors differentiate within a discrete area. The molecular mechanisms that influence cardiomyocyte progenitor selection have not been investigated. Moreover, we are unaware of what is regulating RA signaling. Therefore, the specific aims of my post-doctoral research are: 1) to determine how RA signaling levels affect differentiation of cardiomyocyte progenitors in zebrafish; 2) to determine which RA receptors regulate cardiomyocyte progenitors differentiation; 3) and to identify novel regulators of RA signaling. [unreadable] [unreadable]